Community Outreach and Engagement

ABSTRACT: COMMUNITY OUTREACH AND ENGAGEMENT
Community Outreach and Engagement (COE) is foundational to the success of the Sidney Kimmel Cancer Center (SKCC), as it links the research and investigators at the SKCC to the residents and communities in its catchment area. The 7-county SKCC catchment area consists of 5 million residents who speak upwards of 45 different languages and experience some of the most adverse cancer health challenges of any communities in our nation. The Office of COE was established in 2020 to develop, facilitate, and evaluate COE activities across the SKCC. Currently led by Dr. Amy Leader, the first Associate Director for COE at the SKCC, the Office consists of 3 master’s prepared program managers and 6 additional staff. One of the core functions of the Office is to maintain a robust Community Advisory Board (CAB) as a mechanism of communication between the SKCC and the catchment area. Membership of the CAB is reflective of the communities in the catchment area; the CAB is led by a Community Chair and Co-Chair and reports directly to the Director of the SKCC. Other responsibilities of the Office of COE are to determine the priority cancers of the catchment area and to execute the aims of the Office. The specific aims of the Office are to: (1) identify needs, assess priorities, and continually monitor the catchment area across the cancer continuum; (2) foster bi-directional partnerships with communities to ensure that research and clinical trials are responsive to catchment area priorities; and (3) implement evidence-based interventions, policy recommendations, and public education campaigns across the catchment area to reduce cancer burden. For the first aim, the Office uses national, state, and local data plus its own Catchment Area Report to monitor the trends and needs of the catchment area and provide data to investigators to support catchment-relevant research. For the second aim, the Office supports the Research Programs in developing, implementing, and evaluating research and clinical trials that are relevant to the catchment area, as well as creating novel initiatives to prepare investigators, community members and trainees to participate in COE activities. For the third aim, the Office supports evidence-based initiatives, such as community-based cancer screening and linkage to resources, to further policy and practice in the catchment area. Taken together, these outreach and engagement strategies will allow the SKCC to achieve its broader mission of reducing cancer burden in the catchment area.